Personalized Approach To Habits-Sleep (PATH-S), an app to improve sleep for Black teens (ages 14-17) with asthma

KDH Research & Communication (KDHRC) proposes to develop and evaluate an app, Personalized
Approach To Habits – Sleep [PATH-S], that will use casual gaming and intermittent reinforcement to
encourage Black teens (ages 14-17) with asthma to adopt and persist with personalized habits to improve sleep
duration.
Although sleep is fundamental for human productivity and health, only one quarter of teens in the U.S.
report obtaining recommended amounts of sleep. Sleep problems are magnified among teens with asthma, who
are more likely to experience sleep disturbances like trouble falling asleep, wheezing during sleep, frequent
nighttime wakening, and daytime sleepiness. Asthma symptoms impact sleep, and poor sleep, in turn, worsens
asthma symptoms.
The data on overlapping health disparities for Black teens in regard to sleep and to asthma are stark. Because
being Black heightens the independent likelihood of both poor sleep and having asthma, it is unsurprising that
Black teens with asthma experience worse sleep outcomes than White teens with asthma, and their sleep
problems are likely to persist into adulthood.
In this Phase I proposal, KDHRC will develop and evaluate the PATH-S minimally viable prototype (MVP),
an app that specifically addresses this health disparity and supports Black teens with asthma to build and
persist with habits that will build sleep duration, focus, and attention, and decrease asthma symptoms in turn.
KDHRC will develop and evaluate PATH-S with technical vendor Thrust Interactive, on Thrust’s existing and
research-validated Treks platform. PATH-S will increase user engagement by providing health-related content
in the form of a game that breaks behaviors down into simple, daily, evidence-based tasks that the app refers to
as “micro-habits.” Users can 1) learn healthy sleep habits and create a personalized path to better sleep; 2)
review progress and make plan adjustments; and 3) report their own asthma symptoms and the extent to
which their symptoms impacted them. PATH-S will create competition against other users via a leaderboard
and provide game-like reinforcement for achievements. PATH-S will sync to a FitBit to allow users to track
sleep metrics.
In this Phase I project, KDHRC will receive input from an expert advisory committee, develop the PATH-S
MVP, conduct user testing of the PATH-S MVP, finalize the PATH-S MVP, and conduct a feasibility study of
the PATH-S MVP. To commercialize PATH-S, KDHRC will sell to third party payors, expand PATH-S to
support more audiences at risk for sleep problems, and begin direct-to-consumer marketing.

Public health relevance
Black teens with asthma experience worse sleep outcomes than White teens with asthma, and lack of sleep can worsen disease outcomes. KDH Research & Communication (KDHRC), with technical partner Thrust Interactive, will develop an app-based sleep intervention for Black teens with asthma (ages 14 – 17) that uses casual gaming and intermittent reinforcement to encourage teens to adopt and persist with personalized habits to improve sleep duration. The PATH-S app will sync to a low-cost wearable biometric device that provides biometric data and sleep metrics for tracking improvement and reinforcing success. PATH-S’ ultimate goal is to improve sleep duration, which will relate to subsequent improvements in focus, attention, and reduced asthma symptoms in turn.